Partnering and Programming for a BIPOC SGM Pathway to HIV Research

PROJECT SUMMARY
THIRD COAST CFAR DEi PROGRAM CORE RESEARCH
The Third Coast Center for AIDS Research (TC CFAR) recognizes the need to create career pathways for
Underrepresented Minorities (URM) in the behavioral, health services, social, and/or translational sciences in
order for them to develop successful and impactful careers in research on minority health and health disparities
specifically focused on HIV. For the research workforce to reflect those affected by HIV, it is a high priority for
many more Black, Indigenous, and People of Color {BIPOC) who are also sexual and gender minority (SGM)
persons to enter HIV research. Therefore, by addressing the NIH HIV/AIDS Research Priority, "Research
training of the multidisciplinary workforce required to conduct High Priority HIV/AIDS or HIV/AIDS-related
research," we propose a new TC CFAR Core to specifically address this Priority. The Diversity, Equity, and
Inclusion Program Core (DEIPC) is being proposed to advance the successful Program in lntersectional
BIPOC SGM-focused HIV Science. This new Core will launch in fall 2024 and will leverage the resources and
infrastructure of TC CFAR and those of the Institute for Sexual and Gender Minority Health and Wellbeing
{ISGMH) at Northwestern University. The DEIPC will further establish TC CFAR as a national leader in creating
scientific pathways for training and mentoring BIPOC SGM persons in HIV science and research with BIPOC
SGM communities and populations.